Novel zebrafish model of syndromic craniosynostosis

PROJECT SUMMARY
To enable deformation of the skull during birth and allow for the rapid growth of the brain during early life
stages, the bones of the skull roof are connected through fibrous tissue, called sutures. These sutures only
fully fuse later in life to form a stable brain case. Early fusion of these fibrous connections is called
craniosynostosis and leads to deformations of the skull, which in turn can lead to increased cranial pressure
and restricted brain growth. Craniosynostosis is the second most common craniofacial birth defect, occurring
with a frequency of 1 in 2100-2500 live birth. Craniosynostosis often occur isolated, without additional
malformations, but in 20-25% of cases patients show additional changes like midface hypoplasia and limb
abnormalities (syndromic craniosynostosis). Despite the relatively high incidence, the pathomechanisms
leading to craniosynostosis are still incompletely understood and surgical removal of the fused tissue is the
current standard of care. These surgical procedures bear a risk of high blood loss, and the sutures often re-fuse
requiring repeated surgeries. Therefore, there is a critical need to better understand the pathomechanisms
leading to craniosynostosis to enable the development of alternative, non-surgical treatment strategies. The
zebrafish has become a popular animal model to study human disease and it has been shown that the patterning
of the skull roof as well as the regulatory pathways controlling craniofacial development are highly conserved. In
a genetic screen for mutants with skeletal phenotypes, we have identified a unique mutant that exhibits features
of a severe form of syndromic craniosynostosis with coronal suture fusion, midface hypoplasia, open fontanelles,
fewer teeth, deformed and shorter fin rays and mis-pattered scales. To establish a correlation of the observed
mutant phenotype to the human disease, we will perform comprehensive phenotypic, mechanistic and genetic
evaluation of our novel mutant. In Aim1 we will perform skeletal staining on developmental time series to identify
which stages and skeletal elements are affected in combination with analyses of shape and bone density
changes through micro computed tomography scanning. In a second set of experiments, we will use in vivo
labeling of the growing bones to determine bone formation dynamics of forming skull bones. Finally, we will
determine the mechanical properties of the developing sutures and calvarial bones. In the second aim, we will
define the cellular and molecular mechanisms underlying the CRS phenotype using immunohistochemistry,
transcriptomic and phospho-protein analyses. The third aim will identify the genetic changes responsible for
these severe skeletal phenotypes. We will use CRISPR mediated genome editing to functionally test previously
identified candidate genes and determine their expression pattern. A detailed and broad description of the
phenotypic changes occurring in our craniosynostosis mutant in combination with the mechanistic and genetic
analyses, will serve as a starting point to further elucidate the molecular mechanisms underlying
craniosynostosis and hopefully enable the development of non-surgical strategies strategies in the future.

Public health relevance
PROJECT NARRATIVE The early fusion of the cranial sutures, craniosynostosis, is the second most common craniofacial birth defect (1/2500 births). This project seeks to phenotypically, mechanistically and genetically characterize a new zebrafish model of syndromic craniosynostosis, with the goal to obtain critical data for future work to elucidate the pathomechanisms of CRS to develop novel, non-surgical treatment strategies.